Cleveland Kidney, Urology and Hematology Training Network

Abstract
To meet the needs of those with kidney, urology and hematology related medical
symptoms or conditions, the Cleveland Kidney, Urology and Hematology Research
Training Network has designed a one and a half daylong meeting to educate the next
generation of KUH professionals. This meeting will enable trainees and their senior
colleagues to both learn together and to network. In order for all trainees to have the
opportunity to join this meeting, the Cleveland Kidney, Urology and Hematology
Research Training Network is requesting a supplement to support the travel costs for
these trainees. At the meeting, trainees will benefit from current training which will enable
them to address outcomes important to people with kidney, benign urinary and benign
blood conditions and cure these diseases.
The agenda includes a plenary panel and discussion to include topics such as novel
imaging modalities for early detection of kidney disease, advances and challenges for
hemophilia gene therapy and computational pathology and its impact in urological
diseases. Resources such as the O’Brien Cooperative Research Centers, CAIRIBU
and Cooperative Centers of Excellence in Hematology will be shared. As the meeting is
centered around trainees, required trainee poster sessions and trainee oral
presentations will be held.
In addition, several classes will be available regarding How Scientists Can Develop an
Entrepreneurial Identity, A Guide to Multi-Investigator Grants: What They are &
Development Considerations, How to Negotiate Your First Academic Position, How to
Publish High-Impact Science and The Path from Bench to Bedside: Considerations for
First-in-Human Studies.
The goal of this meeting is to educate leaders for the nation’s KUHR workforce, to
accelerate clinical research education, and to educate all members of the research
team. These trainees will be joining in discussions regarding kidney, urology and
hematology while networking, presenting their research, creating collaborations,
connecting with mentor’s and making new friends. Ultimately, this meeting will impact
the face of KUHR going forward and the more trainees in attendance, the greater
chance of meeting this goal.

Public health relevance
Project Narrative The Cleveland Kidney, Urology and Hematology Research (KUHR) Training Network has designed a one and a half daylong meeting to train the next generation of KUHR professionals. The proposed KUHR meeting seeks to support the development of these emerging investigator leaders who will gain the expertise to provide innovative solutions to the fields of Kidney, Urology and Hematology. To reach the goal successfully, additional funds to support trainee travel from all of the active U2C/TL 1 sites would be extremely beneficial.